Proteomics/Metabolism Core

PROJECT SUMMARY
The ‘Proteomics and Metabolomics’ Core C will be under the administration of Dr. Birgit Schilling, an independent
faculty member at the Buck Institute. Core C will provide state-of-the-art analysis for senescence-related samples
from all three Projects. Dr. Schilling, who is also the Director of the Mass Spectrometry (MS) Facility at the Buck
Institute, will direct the Proteomics and Metabolomics Core and provide all infrastructure, coordination of MS
acquisitions, and training for all participating project leaders and investigators. The Core is very well-equipped
with a total of seven modern mass spectrometric systems, and four mass spectrometers are dedicated to
proteomics research and workflows. The objective of Core C is to provide a common platform across each
Project for the design, execution and analysis of experiments that involve secreted molecules that are key
signaling regulators generated by senescent cells and subsequent effects on our AD models, including induced
pluripotent stem cells (iPS) and organoids. To achieve the goals of this Program Project, Core C will devote its
efforts to the following work: i) determine proteins present in the senescence-associated secretory phenotype
(SASP) from brain specific senescent cells, ii) determine the components of SASP and exosomes from
senescent astrocytes and microglia or senescent-like neurons and their effects on neurons, iii) investigate
organoids and co-cultures from iPSC models of AD, iv) analyze metabolites and measure NAD levels of
senescent cells, and finally v) determine dynamic changes of post-translational modifications of tau. Core C
specifically innovates, develops, and implements advanced protein analytical technologies, including quantitative
proteomics, determination of protein secretomes and exosomes, as well as monitoring the PTM status of disease
proteins, to advance basic biological and biomedical research. To support the projects and aims of this PPG,
Core C will offer a variety of different mass spectrometric workflows, including data-dependent acquisitions
(DDA) for protein discovery and identification, and data-independent acquisitions (DIA or SWATH) for
comprehensive sampling of the SASP and intracellular proteomes with simultaneous accurate relative
quantification. We will use our orthogonal Quadrupole Time-of-Flight mass spectrometers, the TripleTOF 6600
and 5600 (SCIEX). We also just ordered an Orbitrap Eclipse Tribrid (Thermo) mass spectrometer enabling very
deep proteome coverage at very high resolution, sensitivity, dynamic range and also offering excellent
multiplexing capabilities. Our expertise and instrumentation are also particularly well suited for analysis of SASP
that may be dynamically affected during senescence. Continuous system suitability and quality control assays
are acquired to provide highest levels of data reproducibility and scientific rigor. Dr. Schilling’s lab and Core C
will provide all necessary infrastructure and expertise for data analysis and bioinformatic/statistical processing
of the results. We will closely interact with bioinformatics experts in Core A for multi-omics system-wide analysis.